Renal Biology and Disease Training Program

With the rapid accumulation of knowledge resulting from the development of new genetic and proteomic
screens and methodologies, this is an exciting period in biomedical science, and there are now tools and
techniques available to elucidate the underlying molecular etiologies of diseases and use this knowledge to
provide new and more effective treatments or cures. The increasing incidence of kidney disease in the U.S.
and worldwide represents a major challenge to our health systems. There is a growing urgency to train
physician scientists and Ph.D. scientists who can increase our understanding of disease pathogenesis and
develop, implement and assess new therapeutic modalities to combat renal disease. However, during the past
decade, there has been a disturbing decrease in interest in Nephrology as a profession among potential
trainees and especially a decreasing interest in committing to a career in kidney research. Therefore, it is
crucial for research-rich nephrology programs to seek out, train and mentor the next generation of kidney
research scientists. The goal of the Vanderbilt Nephrology Training Program is to provide promising M.D.
and/or Ph.D. postdoctoral fellows with the knowledge and the tools to become the leaders in both basic and
translational research efforts to generate new understanding in the pathogenesis of kidney diseases and to
develop and implement new treatments and cures for our patients with kidney disease. The faculty who
participate in the Vanderbilt Nephrology Training Program represent a group of talented and accomplished
researchers with a broad range of scientific expertise and research interests. This group consists of 29
investigators whose primary appointment is in either Adult or Pediatric Nephrology and 15 other clinical and
basic scientists who have ongoing interests in kidney disease or associated scientific questions. The
training faculty are based in 8 departments: Medicine, Pediatrics, Pathology, Preventive Medicine,
Bioinformatics, Biochemistry, Cell and Developmental Biology and Anesthesia. Research interests of the
primary faculty include mechanisms of chronic glomerular and tubulointerstitial injury, acute kidney injury, cell-
matrix and cell-cell interactions, renal development, epithelial cell biology, eicosanoid biology, epidemiology
of progressive kidney disease, development of clinical biomarkers, health services research and clinical
trials. Our training program is structured to provide physician/scientist (M.D. or M.D./Ph.D.) and selected
basic scientist (Ph.D) trainees with a focused and productive research experience that will serve as the
foundation for an independent investigative career directed toward understanding and treatment of renal
disease.
Project Summary/Abstract Page 6

Public health relevance
The Vanderbilt Nephrology Training Program provides a structured and mentored training experience in basic and clinical and translational research for selected MD and PhD post-doctoral trainees. The goal of this program is to provide the training necessary to develop into an independent researcher in kidney-related research.